Program Enrichment Core

PROJECT SUMMARY/ABSTRACT - ADMINISTRATIVE/PROGRAM ENRICHMENT CORE
The Administrative/Program Enrichment Core will administer and oversee all activities conducted by the
Oklahoma Nathan Shock Center at the University of Oklahoma Health Sciences Center, the Oklahoma Medical
Research Foundation, and the Oklahoma City VA Medical Center. The PEC will continue to publicize services of
the Research Cores, run the Seminar Series in Aging and Geroscience and the Johnson/Sokatch Lectures,
organize the annual Oklahoma Geroscience Symposium, and evaluate performance of Cores, Programs, and the
overall NSC. Together with these activities, to achieve the NSC's goal to enable sustained, accelerated progress
in the biology of aging and geroscience research, the PEC will also administer three new programs: the
Geroscience Biorepository (GBR), the Geroscience Toolbox (GT), and the Geroinformatics Resource (GIR). For
all these programs and activities, outreach, inter-NSC communication and logistics, and their tracking, will be
coordinated by the NSC3. The PEC will advance the NSC's goal with the following aims: Aim 1. Provide
administrative support, and define impact of our NSC through an objective evaluation of Research Cores, NSC
Programs and the overall NSC. The PEC will manage the NSC, promote integration of Cores, and evaluate
performance of Cores, Programs, and the NSC annually by the Internal Advisory Committee; every other year by
the External Advisory Committee; will monitor performance using internal data shared with the Nathan Shock
Centers Coordinating Center (NSC3); and will coordinate with the NSC3 the administration of semiannual user
surveys. Data will be used to evaluate user satisfaction and metrics of Core and overall NSC performance and
impact. Aim 2. Promote/publicize services and activities of the Cores through the NSC3 and the Oklahoma NSC
webpage, the new Geroscience Webinar Series, the NSC's social media platforms together with the Research
Development Core (RDC), participation of NSC leadership in premier aging/geroscience meetings. Aim 3.
Provide intellectual and organizational leadership to grow interest in aging and geroscience in Oklahoma and
the US through the NSC's Seminar Series in Aging and Geroscience, the Johnson/Sokatch lectures, hosting the
NIA Summer Training Course in Experimental Aging Research, participating in NSC3 activities including NSC
Directors' meetings, and organizing the annual Oklahoma NSC Geroscience Symposium and the biennial
Oklahoma Gero-Oncology Symposium. Aim 4. Provide investigators with (a) statistical support and advanced
bioinformatics tools, (b) access to protocols, SOPs, and videos, and (c) access to biosamples and new aging
models for basic and translational research on aging/geroscience through (a) the Geroinformatics Resource (b)
the Geroscience Toolbox, and (c) the Geroscience Biorepository. The PEC ensures effectiveness of Research
Core activities, and works with the RDC ensure access by all US researchers to NSC programs and resources.